Exploring the role of a premotor cell type for active sensor control in Drosophila

PROJECT SUMMARY
An animal’s nervous system enables it to detect and respond to stimuli to navigate its environment. To enhance
sensory acquisition, animals can actively position sensors, altering how they extract information from the external
world. However, active sensing, and movement in general, produces stimuli that feeds back onto these same
sensory systems – requiring mechanisms for integrating predictive motor signals with externally-generated
sensations. Despite the importance of these mechanisms for guiding coordinated behavior, the cellular and
circuit basis of motor control and sensation during active movements are not fully understood. This proposal
aims to determine how mechanosensory information controls motor output in the Drosophila antenna, an active
sensor that can be passively deflected or actively positioned. Previous work shows that APN2, a class of antennal
mechanosensory and motor center projection neurons, contributes to an afferent sensory pathway. However, my
preliminary connectomics and optogenetic behavior data support that APN2 also lies presynaptic to antennal
motor neurons, suggesting a role beyond mechanosensory afference. I hypothesize that APN2, as a premotor
class of neurons receiving direct mechanosensory input, enable active antennal positioning via integration of
sensory and higher-order motor signals. In Aim 1, I will use electrophysiology and quantitative behavior to
characterize the activity of APN2 during different active and passive antennal movements. In Aim 2, I will
measure the relative influence of sensory input on APN2 activity during behavior with electrophysiology and
machine-learning assisted antennal tracking. By defining APN2’s role in antennal motor control, this proposal
will uncover the functional logic of a sensory-motor circuit controlling an active sensor.

Public health relevance
PROJECT NARRATIVE The challenge, or advantage, of sensing during movement is as evolutionarily conserved as motile behavior itself. The experiments proposed here will illuminate fundamental mechanisms of how the nervous system integrates sensory information with motor plans for movement. By elucidating elementary circuit function in Drosophila, this research will increase our understanding of how nervous systems use sensory information to guide coordinated movement and behavior, which is crucial for understanding how these mechanisms fail in disease.